SA-CCRC Administrative Core

SUMMARY (Administrative core)
The Administrative Core of the San Antonio-based Collaborative Research Center on
Coccidioidomycosis (SA-CCRC) will provide essential management and supervision of the
entire range of the Center’s highly multidisciplinary activities to ensure that our specific aims and
component plans are implemented effectively and efficiently. In this core, we outline a
management, coordination and integration framework for the scientific, logistical, financial,
evaluative, and compliance oversight requirements and resource allocation for the cores and
individual research projects. The ultimate goal of this administrative core is to maximize the
impact of overall research activities across the entire SA-CRCC. Within this Administrative Core,
we have designed a framework for assessing the proposed activities of each Core such that we
can ensure progress towards meeting our stated goals. SA-CCRC is designed specifically to
have well-coordinated research that can maximize and leverage resources at each of the
participating institutions. In addition, the Administrative Core will manage the Development and
Research Program (DRP) for pilot funding and mentoring of junior investigators as well as
researchers new to the field of coccidioidomycosis research. We propose the following specific
aims around which we have designed our management processes: Aim 1. To provide scientific
and programmatic leadership, administrative support, and fiscal oversight of the San Antonio-
based Collaborative Research Center on Coccidioidomycosis. Aim 2. To establish and manage
an effective Development and Research Program (DRP) for pilot funding and mentoring of
junior investigators and those new to the coccidioidomycosis field. In summary, through the
Administrative Core we will ensure successful achievement of our program mission by serving
as the central hub responsible for overall program management, resource allocation, logistical
planning, coordination, and oversight of the San Antonio Collaborative Research Center on
coccidioidomycosis. The administrative activities within this core are complemented by a robust
mentoring and professional development program aimed at preparing the next generation of
independent scientists in the field of coccidioidomycosis research.